STRUCTURE, FUNCTION AND EXPRESSION OF MYOSIN AND MYOSIN LIGHT CHAIN KINASE

We are investigating the site(s) of phosphorylation of the nonmuscle myosin heavy chain and the effect of phosphorylation on myosin functions, such as MgATPase activity and filament formation.